DYSBIOTIC MICROBIOME IN PANCREATITIS, DIABETES, AND PANCREATIC CANCER

PROJECT SUMMARY/ABSTRACT
Baylor College of Medicine (BCM) is a clinical center in the Continuation of the Consortium for
the Study of Chronic Pancreatitis, Diabetes and Pancreatic Cancer (CPDPC-2). We are
requesting supplemental funds to our grant award 2 U01 DK108326-09 to cover the clinical care
costs associated with recruiting, enrolling, and following participants according to the
PROspective Evaluation of Chronic Pancreatitis for EpidEmiologic and Translational StuDies
(PROCEED), the PROCEED Substudies and the Evaluation of a Mixed Meal Test for Diagnosis
and Characterization of PancrEaTogEniC DiabeTes Secondary to Pancreatic Cancer and
Chronic Pancreatitis (DETECT) protocols. We will also use these funds for any additional new
substudies approved by the Steering Committee during the CPDPC-2.

Public health relevance
NARRATIVE BCM is a clinical center in the CPDPC-2. We are requesting supplemental funds to our grant award 2 U01 DK108326-09 to cover the clinical care costs associated with recruiting, enrolling, and following participants according to the PROCEED Study, PROCEED Substudies, and DETECT Study protocols. BCM will also use the supplemental funds to recruit patients, procure specimens prospectively, collect epidemiological and clinical data, and contribute to the completion of any new studies approved by the Steering Committee during the CPDPC-2.